MORPHOLOGICAL STUDIES OF LIGAND BINDING TO CELLS

This work represents over 10 years of collaboration between the Diabetes branch and the Institute of Histology and Embryology at the University of Geneva. The initial observations demonstrated that polypeptide hormones are taken up by the cell through a process of receptor-mediated endocytosis similar to other biologically important ligands that bind to cells. In the present study we find a) there is an anatomical correlation between the dissociation of 125I-insulin and its localization on the cell surface. This work has now been extended to include an insulin resistant cell line which has dissociation characteristics which could be explained by this abnormal surface leading to a higher association of ligand to the non-villous portion of the cell surface. In b) we have demonstrated that receptor-mediated endocytosis also appears to be regulated in hypoinsulinemic states, i.e., in both rat and in human type I diabetes there is an inhibition of 125I-insulin internalization in the hyperglycemic state, the normal state is restored by insulin treatment. In c) we have studied the role of intracellular calcium on the endocytotic process as well as the relationship of stimulators of protein kinase C to internalization of both insulin and unrelated ligands such as transferrin. d) In addition, we are studying the function of the small non-coated invaginations in receptor-mediated endocytosis.